The Affordable Care Act: MCV/PCV & Pertussis

DESCRIPTION (provided by applicant): This cooperative agreement will improve surveillance infrastructure through enhancement of the epidemiology and laboratory capacity of the existing EIP network by providing additional support for: 1. Personnel, especially those who have responsibilities across multiple EIP activities; 2. Education and training related to infectious diseases; 3. Improvements in information technology consistent with applicable federal standards and the capacity to exchange information pertinent to multiple EIP activities among public health partners; 4. Enhancement of EIP site capacity to a) support the evaluation and validation of proposed reporting metrics for healthcare associated bloodstream infections among dialysis patients in outpatient dialysis centers and b) monitor and assess the burden of influenza following the 2009-2010 Influenza A (N1N1) pandemic. Proposed Activities 1, 2, and 3 - Personnel, Training, IT For activities 1, 2, and 3, we are requesting funding for 1 FTE Microbiologist who works at the DPH Laboratory. This person will be responsible for testing of specimens for organisms related to FoodNet activities (Salmonella, Shigella, E. coli, Vibrio) as well as the active bacterial core surveillance project (Streptococcus pneumoniae, N. meningitidis, Listeria monocytogenes, Haemophilus influenzae). We are requesting funding for a .5 FTE Epidemiologist who will work in the Infectious Diseases Section and assist with food and water-borne outbreaks, and surveillance for influenza associated hospitalizations and deaths. Funds in this proposal will also support training of EIP staff epidemiologists to acquire and improve technical skills needed for successfully conducting EIP activities. The trainings are held at Emory University in Atlanta, GA. They include control of foodborne and waterborne diseases, epidemiology and analytical methods. The CT EIP is a collaborative effort between the DPH and Yale University School of Public Health. The EIP projects conducted at Yale have relied on computer support from Yale IT staff who are assigned to provide service to the entire School of Public Health community or from IT technical support by telephone in emergency situations. However, with the increasing amounts and complexity of data needed for these projects, to best use epidemiologist staff resources, and to share information with the DPH and CDC, additional IT support is needed. Funds are being requested to support a .5 FTE Programmer/Analyst to provide needed computer and database expertise to the staff of the Yale EIP. At a minimum, this person will be certified in 'desktop support'and have a background in computer network security. Proposed Activity 4a. Influenza The DPH is requesting funding to support a .5 FTE Epidemiologist 1 who will work on influenza associated hospitalizations and deaths. Currently, 1.5 FTE epidemiologists are supported by the EIP for these labor intensive and time sensitive activities. We are also requesting funds for .5 FTE Research Associate at the Yale EIP to carry out the activities of the Influenza Burden Projection Project. This person will work directly with CDC and other EIP sites in the development of the standard protocol to be used at all sites. Additional funds are also requested for a .3 FTE Programmer/Analyst, who will provide the needed computer and database support. This project aims to develop a model for estimating the number of cases, hospitalizations and deaths due to influenza. Development of the model will provide needed information to policy makers when evaluating prevention and control measures. Activity 4.b. Healthcare Associated Infections - (Non-ACA funds) The DPH is requesting funds to support the EIP cooperative agreement Healthcare Associated Infections Program End Stage Renal Dialysis Blood Stream Surveillance special pilot project. The project is part of an initiative for the prevention of blood stream infections among dialysis patients initiated by the Center for Medicare and Medicaid Services and CDC. The Network of New England will be the Group Administrator for the project, enroll dialysis providers, conduct administrative functions such as training and user support with CDC, assure the correct submission of accurate data into the national data system, and report on the lessons learned from the project to CMS and CDC. The funds will include support for a Project Coordinator who will communicate with providers and encourage enrollment in retention in the project and also an administrative assistant who will assist the project coordinator with communication and assist in all aspects of the project.

Public health relevance
Background and Understanding The Connecticut Department of Public Health (DPH) and Yale University School of Epidemiology and Public Health (Yale) are in an ideal position to seek and be provided support to maintain the Connecticut Emerging Infections Program (CT EIP), continue to participate in the national EIP network, and change activities to respond to disease events based on current needs. To maintain the capacity and flexibility to conduct EIP activities, site infrastructure must be periodically evaluated and strengthened. The CT EIP was among the first EIPs funded to be part of the emerging infections network. Original funding in 1994 was awarded to Connecticut in part because DPH had a strong track record of responding to emerging infectious disease issues, collaboration was planned with a highly interested and well-qualified academic partner (Yale), and CT had a wide spectrum of public health problems and a diverse population of a size that was small enough (3.28 million) to conduct statewide surveillance. During our 15 years of operation, we have demonstrated our ability to effectively build and manage an EIP and produce high quality work. We have done this in all EIP functional areas including a) active surveillance, b) applied public health epidemiologic and laboratory studies, c) pilot prevention/intervention projects, d) participation in conceptualization, study design and implementation of new EIP network projects on short notice (flexible capacity); e) development of site-specific pilot projects that have lead to new network-wide surveillance activities; and f) training of the future public health workforce. Throughout, we have collaborated with other EIP sites and CDC both directly and through EIP Steering Committee meetings, maintained the flexibility to respond to emerging problems, and worked to disseminate the information learned via EIP network collaborative publications and presentations to national audiences and interstate colleagues and site-specific publications and presentations to in-state audiences and partners. As part of being an EIP site, we have established ongoing collaborative relationships with the clinical laboratories, hospital infection control units, local health departments, and infectious disease clinicians throughout the state, including them as special groups in our state Health Alert Network. In developing and carrying out the CT EIP, we have learned a number of valuable lessons, including ones in management of an EIP site that have lead to our current administrative structure. Furthermore, we have tried to integrate public health preparedness funding and surveillance initiatives into the EIP so that the objectives of both efforts are mutually enhanced. Important for a high level of level of involvement in EIP network leadership, there has been stability in key staff. For the past six months, the Centers for Medicaid and Medicare Services (CMS), the CDC, the Connecticut and Massachusetts Departments of Public Health, and the End Stage Renal Disease (ESRD) Network of New England have been collaborating on a proposed, but not yet initiated, project to foster the enrollment of hemodialysis centers in New England into the CDC National Healthcare Safety Network (NHSN), the online Healthcare Associated Infection (HAI) surveillance database. The intent of this proposed surveillance system is to gather baseline and ongoing Blood Stream Infection (BSI) data that can be used to manage and track the effectiveness of prevention projects aimed at reducing the number of vascular access infections in freestanding and hospital-based dialysis centers. CMS is also evaluating the feasibility of expanding this regional pilot into a national reporting requirement for all CMS-provider dialysis centers and for integrating the surveillance into the development of the CMS's CROWN Web clinical data system. The CT HAI Program has been heavily engaged in the development of the 2nd Phase Hospital Prevention Survey Pilot and the Denominator Simplification project, the two inaugural projects of the CDC HAI EIP Steering Group. The CT HAI Program Coordinator also participates on the EIP Dialysis Working Group and the ESRD Executive Director participates on the legislatively authorized DPH CT HAI Advisory Committee. The CT HAI Program has entered into contractual agreements to financially support collaborative prevention activities in the state (the CUSP Stop BSI Project and the Qualidigm [CMS QIO] MDRO prevention project). The program has also collaborated with hospitals in the state for the Phase 2 pilot of the Point Prevalence Survey, which has involved human subject review of the research protocol by the DPH and hospital Institutional Review Boards (IRBs). Need Activities 1,2, and 3 The Foodborne Diseases Active Surveillance Network (FoodNet) is one of the core projects of the EIP. Within this project, enhanced outbreak detection and investigation is a core activity. In the CT EIP, the Yale EIP has primary responsibility for conducting active laboratory-based surveillance for foodborne diseases, while the DPH has primary responsibility for conducting outbreak detection and investigations. Currently at DPH, one EIP FoodNet-funded epidemiologist, serving as the Outbreak Coordinator, is responsible for statewide outbreak detection and investigations. On average, CT investigates 15-20 foodborne, waterborne, and other enteric disease outbreaks each year. In addition to these known outbreaks, numerous pulsed-field gel electrophoresis (PFGE)-defined clusters (including multistate clusters) are identified and investigated to varying but lesser degrees. Successful outbreak detection and investigation are labor intensive activities. Additional epidemiologic capacity is needed to assist the Outbreak Coordinator with monitoring of surveillance and laboratory data to identify outbreaks, conducting routine and outbreak-related epidemiologic interviews, coordinating investigations with other involved entities (including local health departments, State Laboratory, DPH Food Protection Program, other state agencies, other state health departments, and federal partners), and ensuring timely and complete of reporting of outbreak data to the National Outbreak Reporting System (NORS). Surveillance for Acute Viral Hepatitis (A, B, and C) is also a project of the CT EIP. Hepatitus A Virus (HAV) surveillance is conducted however, without specifically dedicated EIP funds. Currently, HAV related activities . include: a) maintenance of laboratory reporting for markers of acute HAV, b) follow-up of reports of laboratory markers for acute HAV infection to determine case status, c) investigation of cases of acute HAV to determine clinical manifestations, laboratory findings, and risk factors, d) collection of serologic specimens on confirmed cases of acute HAV for molecular characterization at CDC, e) completion of the Viral Hepatitis Case Report form for reported cases and monthly data submission to CDC via an ftp site and to NETSS weekly according to CDC specifications, and f) collaboration with CDC on improving quality of existing data. During 2009, the DPH received a total of 107 IgM (+) HAV reports requiring follow-up with the reporting laboratory and ordering physician in order to determine case status. Of the 107 reports, 18 (16.8%) met the case definition (CSTE/CDC Case Definitions for Infectious Conditions Under Public Health Surveillance). Of the 18 confirmed HAV cases, risk factor information was obtained for 16 (88.9%) cases through case interviews. To maintain the current level of activity as well as improve on quality and completeness of data collection and reporting to CDC, additional epidemiologic resources are needed for these labor intensive activities. The DPH Laboratory currently provides laboratory surveillance data for a number of infectious agents funded through the EIP cooperative agreement and is in need of a senior level staff person to coordinate implementation of new testing methodologies, training of staff and data management. EIP surveillance activities currently include: S. pneumoniae, N. meningitidis, L. monocytogenes, H. influenzae (ABCs), Salmonella, Shigella, E. coli, Vibrio, Norovirus (PulseNet & FoodNet) and Influenza. In 2008, the laboratory received 817 isolates for the ABCs program, performed 613 subtypings by PFGE, tested 631 food samples for Salmonella, tested 178 stool samples for Norovirus. In the same period, the laboratory was involved in approximately 25 cluster/outbreak investigations for foodborne illness, often initiated by identification of clusters by PFGE. Consequently, the laboratory tested over 1100 stool specimens at the request of DPH infectious disease epidemiologists. Recently the laboratory has validated CDC multiplex PCR methods for STECs and campylobacter speciation and pyrosequencing of H1N1 for drug resistance mutations. Timely communication between laboratory staff, DPH epidemiologists, the CDC, local health directors, infectious disease physicians and clinical laboratories is essential for identifying potential outbreaks and characterizing changes in emerging pathogens targeted by the CT EIP. The laboratory has relied on an antiquated laboratory information management system (LIMS) to manage its data; the primary limitation of which is the secure transfer of data to external partners. The laboratory began implementation of a new LIMS system, ChemWare Horizon, in January of 2010. A completion date of all tests is expected by November 2010. The Horizon software has autofax and HL7 send/receive capabilities as well as Web portal access to results. These features will greatly improve the access and flow of data to and from the laboratory. A senior level laboratory coordinator, with experience in both conventional and molecular microbiologic methods and with familiarity with managing laboratory data is needed and will help assure efficient utilization of laboratory testing efforts for disease prevention. Activity 4a In Connecticut, the 2009 influenza A (H1N1) pandemic began in April 2009 and bridged two influenza seasons. The 2008-2009 and 2009-2010 seasons lasted longer than usual with influenza cases occurring through the summer months. During the pandemic, the DPH received the highest number of laboratory confirmed influenza reports since 1976, when influenza first became a laboratory reportable condition. The duration and intensity of disease transmission, uncertainty regarding disease severity and the need for prevention guidance required an ongoing public health response including maintenance of influenza monitoring systems. The DPH conducted enhanced influenza surveillance using multiple systems to characterize the activity level, susceptible population groups, severity, and duration of the influenza seasons, These systems included laboratory reporting of positive test results, sentinel network of providers, hospital-based syndromic systems, required reporting of fatal cases and patients hospitalized for influenza related illnesses. Results of these monitoring efforts were shared in state and with neighboring states' well as with the CDC, contributing to national surveillance and research activities. Currently, there are no EIP funded influenza surveillance staff at the DPH. One 0.5 FTE epidemiologist is supported by the Epidemiology and Laboratory Capacity cooperative agreement to maintain the ILI Provider Sentinel System. Additional personnel are needed to assist with labor intensive surveillance activities and timely reporting of surveillance information from the various systems as well as the additional proposed activities. To provide improved national and regional seasonal influenza burden projections CDC needs to refine and adapt the 'pyramid' model developed during the 2009 influenza pandemic. Additional data are needed to refine and adapt the pyramid model to seasonal influenza; specifically, the incidence of pneumonia and influenza hospitalizations; the proportion of pneumonia and ILI hospitalizations tested for influenza and proportions positive by various test methods and the number and age distribution of deaths from influenza hospitalization. Influenza is a reportable laboratory finding in Connecticut. Beginning with the 2009-2010 influenza season, hospitalized influenza is also a reportable condition in Connecticut. Beginning in the 2003-2004 influenza season, the EIP has participated in the multi-site surveillance for influenza hospitalizations in collaboration with other EIP sites and the CDC influenza branch. Initial surveillance was for pediatric laboratory-confirmed influenza hospitalizations from a 12-town catchment area around Yale-New Haven Hospital and the Hospital of St Raphael. Surveillance has since expanded to include adult and pediatric laboratory-confirmed influenza -related hospitalizations in all 27 towns of New Haven County. Through this surveillance activity, Yale EIP staff have developed close working relationships with the Infection Preventionists and the Information Technology and Medical records staff at all New Haven County hospitals. In 2004, the Yale EIP established population-based surveillance for pneumonia hospitalization in a 7-town catchment area in New Haven County where > 90% of patients requiring hospitalization for pneumonia or other lower respiratory infections were admitted to one of two surveillance hospitals. Surveillance data were gathered on all pneumonia admissions to Yale- New Haven Hospital (YNHH) and the Hospital of St Raphael from residents of the catchment area. Case finding was accomplished at YNHH through daily queries of hospital admission data for specific ICD-9 codes and admission diagnosis text/words consistent with a diagnosis of infectious pneumonia or other lower respiratory track (LRTI) infection. Results of these queries were sent electronically to the Yale EIP Office. In addition, weekly summary reports were generated and emailed to the Yale EIP surveillance officer. To ensure that cases were not missed, a dataset of patients whose hospital discharge diagnosis contained ICD-9 codes indicative of pneumonia or LRTI was generated on a monthly basis and compared to the list of potential pneumonia admissions. Medical charts of potential pneumonia admissions were reviewed to verify diagnosis and abstract pertinent data. Yale-New Haven Hospital's medical records have been computerized, providing rapid, convenient access to demographic, clinical, laboratory and imaging information. Because of the EIP's affiliation with the Yale School of Medicine/Yale School of Public Health, most YNHH medical chart information is available to Yale EIP staff from their desktop computers. Similar methods were utilized to identify cases at the Hospital of St. Raphael. Between April 1, 2004 and March 31, 2005 there were 73,163 hospital admissions at YNHH and HSR. Of these, 36,857 (50%) were from our catchment area. Of the 2,951 pneumonia admissions from the catchment area, 1,826 (62%) met the case inclusion criteria of having radiographic evidence and two or more clinical signs/symptoms suggestive of severe pneumonia. The crude annual incidence was 6.2 cases per 1,000 population. Of the 1,826 cases , only 28% (508) had a putative etiology identified for their pneumonia. Of these 137 had a viral etiology identified; 78 (57%) influenza (A and/or B) and 48 (35%) RSV. The proposed project will utilize the surveillance experience and expertise developed through the Enhanced Pneumonia Surveillance Activity (EPS) to identify and characterize pneumonia outcomes among patients hospitalized with influenza. Established in 2004, the Hospital Emergency Department Syndromic Surveillance (HEDSS) System monitors emergency department visits. The HEDSS System, receives daily electronic reports of chief complaint strings from 19 of 31 acute care hospitals listing total patient visits and age, gender, zip code and time of visit. These data are reviewed for patterns that may indicate the presence of agents of bioterrorism or emerging infections. Three syndromes from the HEDSS System --"flu + fever," "respiratory," and "cold" -- are used in tracking seasonal influenza and EDSS is considered part of CT's pandemic influenza surveillance system. Yale- New Haven Hospital participates in this activity. In response to the September 11, 2001 World Trade Center Attacks, the CT DPH initiated a hospital admissions syndromic surveillance system (HASS) to monitor for possible concurrent biologic attack. This system has continued to the present. Hospital Admission Surveillance System (HASS), receives daily electronic reports from all 31 Connecticut acute care hospitals. listing their total admissions in various diagnosis /syndromic categories:1) pneumonia, 2) hemoptysis, 3) acute respiratory distress syndrome (ARDS), 4) Meningitis, encephalitis or unexplained acute encephalopathy, 5) non-traumatic paralysis, Guillain-Barré or descending paralysis, 6) Sepsis or non-traumatic shock, 7) fever & rash, 8) fever of unknown origin, 9) gastrointestinal symptoms as vomiting, diarrhea & dehydration, 10) skin infection, and 11) clusters of illness The HASS has proven to be extremely useful for tracking seasonal influenza among Connecticut populations and is now considered part of CT's pandemic influenza surveillance system. Similar to HASS, this surveillance system monitors emergency department visits. The EDSS System, receives daily electronic reports of chief complaint strings from 19 of 31 acute care hospitals listing total patient visits and age, gender, zip code and time of visit. These data are reviewed for patterns that may indicate the presence of agents of bioterrorism or emerging infections. 3 syndromes from the EDSS System--"flu + fever," "respiratory," and "cold"--are used in tracking seasonal influenza and EDSS is considered part of CT's pandemic influenza surveillance system. Yale New Haven Hospital participates in this activity. Data on Connecticut residents presenting with influenza-like illness (ILI) is collected on a weekly basis by participants of the US Outpatient Influenza-like Illness Surveillance Network (ILINet) (formerly known as the U.S. Influenza Sentinel Provider Surveillance Network. In CT, 31 sentinel providers report baseline acute care visits and those that meet CDC ILI-definition. Data collected weekly include # of patients with ILI (fever > 100 F and cough and/or sore throat) by age groups (0-4, 5-24, 25-64 and > 64 years). Also collected is the total number of patients seen for any reason (total of ILI + non-ILI cases for all age groups combined). Activity 4b. Dialysis Centers As cited in by Szezech and Lazar (Kidney International (2004) 66, S3-S7) current projections by the National Institutes of Diabetes and Digestive and Kidney Diseases indicate that the population of patients with ESRD will rise from 400,000 patients currently to more than 2 million by 2030. According to the CDC (http://www.cdc.gov/nhsn/psc_da_de.html; accessed 8/18/10) bacteremia and localized infections of the vascular access site are common in hemodialysis patients. Among patients with a hemodialysis catheter, the rate of catheter-related bacteremias has been estimated to be 0.9 - 2.0 episodes per patient-year. Infections, including bacteremia, are the second leading cause of death among hemodialysis patients. National data also demonstrate that cause-specific hospitalization rates among hemodialysis patients have increased 29% for bacteremia and 24% for cellulitis since 1993. Such infections are potentialy preventable, and there are evidence-based guidelines for infection prevetion ("Guidelines for the Prevention of Intravascular Catheter-Related Infections" MMWR; 51(RR 10); 1-26). Effective, nationwide, center-specific surveillance linked to prevention intiatives and collaboratives (such as the Delvarva Foundation-facilitated hemodialysis prevention collorative supported by the CDC) is a worthwhile area for HAI-EIP program intervention. The large number of outpatients with ESRD, and the need for them to receive outpatient hemodialysis on a regular (typically three times per week) basis, requires a large cadre of outpatient hemodialysis providers to serve them. In Connecticut as of June 30, 2010, there were 40 dialysis providers treating 3,208 in-center hemodialysis patients and 518 patients at home on hemodialysis or peritoneal dialysis. The 40 providers have the following corporate ownership composition. Affiliation # of Facilities % DaVita 19 47.5 Dialysis Clinic, Inc. (DCI) 2 5 Fresenius Medical Care (FMC) 12 30 Independent 6 15 Veterans Administration 1 2.5 Total 40 100 There are several barriers related to the participation of providers that need to be overcome in the pilot project. Use of NHSN requires formal enrollment of the center, training and certification and approvals, and sustained effort to complete data entry consistently and on time. This has posed a challenge getting commitments from the independent centers to participate. Some Large Dialysis Organizations (LDOs) have expressed similar concerns, they already collect informantion from the centers, so this may require redundant data collection and entry. There are a few chronic units based within hospital systems that are part of this initiative and their hospitals already use the NHSN reporting system, so this group may be easier to enroll. In addition, most centers do not have the kind of dedicated infection prevention staff that acute care hospitals have to mange NHSN enrollment, data entry, and validation activities. This preliminary assessment suggests that dedicated staff will be needed to devote considerable time to communications with center administrators and staff of the centers to ensure a diverse group of centers enroll. To ensure the centers both enroll and stay active in the project, dedicated project staff will be essential for continuing training, data checks and validation, monitoring of participation, and technical assistance to the centers. Operational Plan Activity 1,2,3 To enhance existing capacity the DPH will establish an additional epidemiologist position within the Epidemiology and Emerging Infections Program (EEIP). Responsibilities for this position will be broad in scope, crossing multiple EIP activities, and flexible to adapt to the changing needs of the CT EIP. This position will assist Program staff with outbreak investigations and infectious disease surveillance systems. The majority of time will be devoted to identification and investigation of food and water-borne outbreaks and HAV surveillance under the direction of the Outbreak Coordinator. The epidemiologist will assist the Outbreak Coordinator with monitoring of surveillance and laboratory data to identify outbreaks, conducting routine and outbreak-related epidemiologic interviews, coordinating investigations with other involved entities (including local health departments, State Laboratory, DPH Food Protection Program, other state agencies, other state health departments, and federal partners), and ensuring timely and completeness of reporting of outbreak data to the National Outbreak Reporting System (NORS). In addition, the epidemiologist will assist with HAV related activities including: a) maintenance of laboratory reporting for markers of acute HAV, b) follow-up of reports of laboratory markers for acute HAV infection to determine case status, c) investigation of cases of acute HAV to determine clinical manifestations, laboratory findings, and risk factors, d) collection of serologic specimens on confirmed cases of acute HAV for molecular characterization at CDC, e) completion of the Viral Hepatitis Case Report form for reported cases and monthly data submission to CDC via an ftp site and to NETSS weekly according to CDC specifications, and f) collaboration with CDC on improving quality of existing data. With experience in both conventional and molecular microbiologic methods and with familiarity with managing laboratory data the proposed senior laboratory coordinator will: a) work with laboratory staff to maintain current testing requirements for EIP pathogens, b) provide timely information to relevant parties on laboratory tests for outbreak investigations and high profile pathogens such as Listeria and E.coli O157:H7, c) ensure laboratory staff implement new test methods as specified by EIP intitatives, d) work with IT staff and epidemiology staff to define the parameters (data fields) and processes for access and transfer of appropriate laboratory data from Horizon, and e) manage and maintain the integrity of laboratory data of EIP pathogens. Activity 4 a The Yale EIP will work collaboratively with CDC and the other funded sites to develop a standard protocol that will be implemented across sites. This protocol will provide needed data to refine and adapt the 'pyramid' model developed during the 2009 influenza pandemic to provide improved national and regional seasonal influenza burden projections. The 4 areas to be addressed under this activity are listed below along with the proposed operational plan. The CT EIP will modify these plans as necessary to conform with the standard protocol to be developed. 1) Measure the incidence of pneumonia and influenza in hospitalized persons as recorded by current testing practices using admission and discharge data: ¿ This activity will be limited to Yale New Haven Hospital (YNHH). Yale EIP currently conducts population-based surveillance for influenza hospitalization at YNHH. All New Haven County residents hospitalized with a laboratory-confirmed influenza infection are identified by this surveillance activity. To measure the incidence of pneumonia we will use data from the 2004-2005 EIP Enhanced Pneumonia Surveillance (EPS) activity (see above). We will work with YNHH IT staff re-establish the daily/weekly queries of hospital admission data for specific ICD- 9 codes and admission diagnosis text/words consistent with a diagnosis of infectious pneumonia. We will also re-establish the monthly query of hospital discharge data developed for EPS. Limited clinical data will be abstracted to verify pneumonia diagnosis and identify potential etiology of the pneumonia. Data from the prospective surveillance system for pneumonia will be compared with EPS data from 2004-2005. 2) Measure the proportion of hospitalized patients with pneumonia and ILI being tested for influenza and the types of influenza tests used: ¿ Yale EIP staff will determine whether cases of pneumonia identified through activity 1, above, were tested for influenza by reviewing electronic medical chart of pneumonia cases to determine if they were tested for influenza and, if so, by what test methodology. To measure the proportion of hospitalized patients with ILI being tested for influenza, Yale EIP staff will work with YNHH IT staff to develop an admission diagnosis query (combining ICD-9 codes and key words from the admission diagnosis) to identify patients hospitalized with ILI. Yale EIP staff will review the electronic medical record of these patients to abstract data necessary to confirm ILI case status and influenza testing data. 3) Calculate the number and age distribution of deaths with laboratory confirmed influenza in the catchment area: ¿ Retrospectively, Yale EIP staff will request electronic death certificate data from CT- DPH for all New Haven County residents who died in 2005-2010. Electronic death certificate data will be cross-matched with cases of influenza-related hospitalizations among New Haven County residents from the 2005-10 influenza season. If a match is found, data will be entered in an Influenza Death Matching Database including date of birth, date of death, and specific cause(s) of death. Prospectively, on a monthly basis, Yale EIP staff will query the on-line Social Security Death Index database to identify any deaths among cases of influenza-hospitalization from New Haven County. If a match is found, date of death will be entered into the SSDI section of the Influenza Death Matching Database. This project poses minimal risk of harm to patients. No patient contact will occur as part of any of the data collection for the death matching. Instead, two existing databases will be linked. The influenza- hospitalization death matching project will begin once the standard protocol is completed. This protocol will build on the methods developed for the previous Influenza Death Matching Study (2007). We anticipate beginning the project in the first quarter of 2011. 4) Measure the incidence of influenza-like illness (ILI) in the EIP catchment areas and the proportion tested for influenza: ¿ Yale EIP staff will work with CT DPH to measure the incidence of ILI in New Haven County. DPH staff maintains both the sentinel ILI surveillance system and the Hospital Admissions Syndromic Surveillance (HASS) and Hospital Emergency Department Syndromic Surveillance (HEDSS) systems. Data from all three of these systems will be used to estimate the incidence of ILI among county residents. The proportion of the cases of ILI tested for influenza will be estimated by comparing the total number of reports of laboratory positive influenza infections reported to DPH from New Haven County residents with the estimated number of ILI in New Haven County. Activity 4b All the ESRD Dialysis facilities in the state of Connecticut will be invited to participate. Special efforts will be made to recruit providers who are motivated and interested in working to identify setting-specific barriers and challenges, able to identify workable and practical solutions to IT barriers, open to innovation, able and willing to collect and share data in a uniform fashion, and excited by the prospect that their participation will likely have major and enduring impact on the health of hemodialysis patients not only in participating dialysis facility, but across the Nation. The project will aim to enroll both independent and LDO affiliated centers. The NHSN Dialysis Event (DE) module will be used to conduct the infection surveillance. The ESRD Network will be the NHSN Group Administrator, and the Network will see individual facility data when the participating centers confer rights to the Network (they will not confer rights to DPH for this project as DE data is not currently reportable in Connecticut). The New England Network will be responsible for enrollment of providers and conducting administrative functions that enables the data entry by providers. The Network will also be responsible for training and user support with the assistance of CDC and Connecticut DPH. DPH will co-host training events and some user support. Facilities enter the data in the tool using two forms. Denominator data are captured on an Outpatient Dialysis Center Practices Survey form completed monthly. It counts all hemodialysis patients in the first week of the month. Numerator data are collected for each patient who has an event on a Dialysis Event form. Data are categorized by type of pathogen (gram positive organisms, gram negative organisms and other organisms) and type of vascular access. The Network of New England will analyze the data to develop baseline event rates for the centers that can be used to track the effectiveness of future interventions to decrease vascular access infections and BSI. Regular and effective communications will be key to the success of the project. Conference calls at regular intervals with enrolled providers, participation in conference calls with state departments of health and CDC/CMS, validate data for providers, etc. Because the Network serves the entire six-state New England region, the Network will be situated to expand the project beyond Connecticut, if CDC and the other New England states are interested. This has the pot...